Zeiss LSM 980 with Airyscan2 for Biological Studies at the University of South Carolina

PROJECT SUMMARY/ABSTRACT
The Department of Drug Discovery and Biomedical Sciences (DDBS) at the University of South Carolina
College of Pharmacy is home to more than 20 faculty members with active research programs in cancer
and neuroscience. Nearly every faculty member in DDBS is supported by active NIH or NSF research
grants. Moreover, the department hosts the Center for Targeted Therapeutics, which is supported by an
NIH-COBRE grant totaling over $10 million from 2014-2024. However, this grant mechanism does not
allow for large equipment purchases in its current phase. Since it was acquired in 2011, the Zeiss LSM
700 confocal microscope has been the main imaging resource for most of the research projects
conducted at the. Researchers from DDBS and neighboring departments have become active users of
the confocal imaging services. The expanding user base and established new research collaborations
have contributed to the success of USC research communities. For example, our federal fiscal year 2020
federal funding was $4.2 million, while our most recent funding level for FY2023 was $14.8 million, with
total NIH funding for FY2023 of $9,279,420. However, a few years ago, the old LSM 700 started to show
signs of decline. Several repairs have slowed the process, but ultimately the microscope is becoming
less and less functional. This application is a collaborative effort of main users from different USC
departments to secure financial resources to acquire a replacement for this key instrument. It is essential
for many active NIH-funded research projects as well as for many new grant proposals currently in
progress. The requested Zeiss LSM 980 ($749,981.64) confocal microscope is the new generation of the
Zeiss LSM product line, which can cover all current imaging activities while providing enhanced image
quality and much-needed new imaging capabilities, including better spatial resolution, faster scans, and
advanced spectral imaging and photomanipulation options.

Public health relevance
PROJECT NARRATIVE Dr. Sikirzhytski, Director of the Microscopy Core at the Center for Targeted Therapeutics at the University of South Carolina, submits this NIH S10 SIG application to fund the purchase of a replacement for the malfunctioning and discontinued Zeiss LSM 980 laser scanning confocal microscope, the sole source of confocal imaging services within the entire main USC campus.